SToP Cancer SPORE: Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM: ABSTRACT
The Developmental Research Program (DRP) is critical to the UNC SToP Cancer SPORE mission to advance
basic understanding of pancreatic cancer development and progression, and to develop new therapeutic
approaches. The overarching goal of the SPORE DRP is to identify and provide research support for innovative
projects that provide key insight into critical areas of pancreatic cancer research. Funded DRP projects should
provide compelling evidence of potential to develop into full projects within the SPORE and/or to be funded by
peer-reviewed federal (NIH/NCI, DOD) or foundation resources. Each year with institutional support, the DRP
intends to fund up to three projects of approximately $100,000, with a second year of funding dependent on
progress in the first year. Budget flexibility will be built in if the senior leadership determines that a project
is particularly promising. RFAs for the UNC SToP Cancer SPORE developmental projects will be offered once
a year, with proposals solicited from UNC, and our sister institutions which include NC State University
(NCSU) and NC Central University (NCCU, a historically black college/university). The DRP Review
Committee (DRPRC) will review applications focused on pancreatic cancer basic research (such as cancer
cell signaling, cell biology, and genetics); translational research (biomedical engineering [BME],
cancer imaging, cancer immunology/immunotherapy, and therapeutic approaches); and population
research, including cancer prevention and control.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM: PROJECT NARRATIVE The Developmental Research Program of the UNC Pancreatic Cancer SPORE supports developmental research into causes and treatment of pancreatic cancer. Announcements for funding will be widely distributed to all UNC faculty and to partner institutions. Evaluation of projects will be performed by the DRP review committee.